NIAID/Division of AIDS: Regulatory Support Center

The purpose of this contract is for the operation and management of the NIAID Division of AIDS (DAIDS) Regulatory Support Center (RSC). The RSC provides comprehensive clinical regulatory and administrative support services for NIAID-supported HIV/AIDS clinical trials and clinical research, both domestic and international.